Center for Virtual Care Value and Equity (ViVE)

Abstract
Importance: Despite the emergence of virtual care (VC) programs during the COVID-19 pandemic, the
sustainability of these programs is unknown because of concerns relating to health access disparities, future
payment parity, effective integration into clinical workflows, and the misalignment of many of the goals of VC
integration with a fee-for-service payment environment. Lack of access to Real-World VC Data and knowledge
of the unique needs of different VC stakeholder groups exacerbates health disparities and can impede
attaining financial sustainability. Similarly, there is no consensus on evidence-based research measurements
specific to VC, which hinders the effectiveness and sustainability of VC
Objective: Lay strong foundation for future adoption and dissemination of VC research capabilities.
Specific aims: (1) Build and promote a productive coalition of internal and external resources, thought leaders
and stakeholder representatives to enable the use of Real-World VC Data and to generate innovative and
pragmatic approaches to advance scalable equity and value in VC both locally and nationally.
(2) Assess the facilitators and barriers for key stakeholders to achieve equitable and sustainable VC by
conducting two rounds of semi-structured interviews.
(3) Develop and validate consensus around VC Equity and Value frameworks (e.g., outcome metrics) that will
accelerate future translational research and provide evidence-based guidance for VC service and policy.
(4) Train workforce to implement validated VC Equity and Value frameworks to improve human health.
Center Activities: ViVE will continuously grow by learning from conducting its research and supporting the
research of others. To the extent, ViVE will create new infrastructure and provide access to Real-World VC
Research Data and VC Expertise that will support and advance VC research. ViVE will assess the facilitators
and barriers to achieving equitable and sustainable VC from key stakeholders using semi-structured
interviews. Additionally, ViVE will shift the current status quo of VC research by building consensus around VC
equity and value frameworks. To ensure the effective implementation of these frameworks, ViVE will conduct
workforce training sessions to improve the knowledge and skills required to implement VC frameworks.
Expected outcomes: On successful completion of our research, we expect contributions to include (1)
accelerating NC TraCS (UNC CTSA) clinical and translational science by expediting the development of a VC
research hub, (2) developing a VC coalition that advances translational VC research by enabling researchers
to access Real-World VC Data, resources, and expertise, (3) building and validating VC measurement
approaches and outcomes metrics for equity and value, and (4) demonstrating real-world utility of validated
outcomes and measurements through implementation in clinical research studies.
Page 1 of 1

Public health relevance
Project Narrative This Center aims to advance the clinical and translational research of virtual care by building a coalition of Real-World Data, experts, and validated frameworks that enable researchers and organizations to ensure equitable and sustainable virtual care by supporting implementation science and workforce development.